Gene Regulatory Networks that Establish Mandible and Maxilla Patterning

Abstract
Craniofacial abnormalities affecting the mandible, maxilla and jaw joint are commonly encountered birth
defects, most of which require surgical correction to establish quality of life and in some cases survival. While
one or more organizing centers within the developing pharyngeal arches, from which the face arises, may hold
the key to understanding the etiologies of these defects, the existence of such centers has never been proven,
leading to a poor understanding of how gene regulatory networks are regulated and integrated during facial
development. This limiting knowledge stifles new approaches to efficaciously treat these deformities.
Endothelin1 (through DLX proteins) and BMP (through SMAD proteins) signaling establishes positional and
structural identity of neural crest cells within the ventral mandibular arch. This is primarily achieved by induction
of the basic bHLH transcription factor HAND2. HAND2 and BMP synergy is required for induction of the bHLH
factor HAND1 within the ventral-most “cap” of the mandibular arch. Interestingly, altering HAND1 dimer partner
choice (thus altering HAND1-mediated signaling) results in pronounced mid-facial clefting, even though Hand1
is not expressed in the mid-face structures. Our data shows that loss of either BMP or HAND2 activity disrupts
the establishment of the ventral cap. These findings establish our hypothesis that the intersection of BMP and
HAND2 activity establishes a ventral cap-signaling center, which acts in both cell and non-cell autonomous
manners to drive upper and lower jaw development. Additionally, we hypothesize that DLX activity antagonizes
BMP/HAND2 synergy. This proposal takes advantage of the craniofacial development expertise of Dr. David
Clouthier, the bHLH signaling expertise of Dr. Anthony Firulli and a number of novel mutant mouse alleles to
test these hypotheses in two Aims. In Aim 1, we will use single cell (sc) RNA-seq to define the gene regulatory
networks that are initiated by the coordinated action of both HAND2 and BMP that act either in an autonomous
(ventral cap) or non-cell autonomously (more dorsal first arch areas) manner. Following analysis of scRNA-seq
data, the top HAND2/BMP effector candidates will be functionally evaluated in loss-of-function and genetic
studies. In Aim 2, the role of DLX proteins in confining ventral cap size will be examined using a novel gain-of-
function Dlx5 mouse allelefollowed by functional testing of DLX action by creating a Hand1 mouse mutant
lacking DLX cis-element inputs. Together, these novel approaches will provide the first direct evidence that the
mandibular arch ventral cap is a signaling center required for facial development.
Relevance: Craniofacial abnormalities are common and require intensive reconstructive surgical corrections.
HAND2 and BMPs play key roles in patterning the neural crest cells that form the face. Gaining insight into the
molecular mechanism of this understudied developmental process could have great potential for initial
development of non-surgical treatments for congenital craniofacial defects in patients.

Public health relevance
Project Narrative This goal of this proposal is to understand the role of BMP signaling and HAND2 activity in establishing a ventral cap signaling domain in the mandibular arch and the role of DLXs in restricting ventral cap function. The proposed research is important, as craniofacial abnormalities are a significant burden to public health. Elucidating the basis of a central signaling center in facial development is crucial to future development of potential treatments, and therefore this research proposal addresses an important human health problem aligned with the mission of the NIH.